Project 2 - Macrophage regulation of fibrosis and scarring during tissue regeneration

PROJECT 2 (Godwin) PROJECT SUMMARY
The lack of scar-free healing and regeneration in humans imposes severe limitations on functional
recovery after major traumatic injury, surgical interventions and disease. Default wound-repair in most adult
human tissues initiates the formation of a protein/carbohydrate fibrotic network that progressively matures into
dysfunctional scar tissue. In organs like the heart, lung and liver, formation of scar tissue can be deadly and
contributes to ~45% of all U.S. deaths. Development of therapies that activate regeneration and scar-free
repair programs in humans will transform modern healthcare.
In contrast to humans and most other mammals, salamanders are capable of scar-free regeneration of
almost all complex tissues including the limbs, heart, brain and spinal cord. Using the salamander as a model
system, we recently demonstrated for the first time the critical role of the innate immune system in regulating
scar-free regeneration. Specifically, we showed 1) that early infiltration of macrophages into damaged limb or
heart tissue actively suppresses fibrosis and 2) that suppression of fibrosis is an essential step required for
normal regeneration to occur.
The cellular and molecular mechanisms by which macrophages suppress fibrosis after injury are
completely unknown. The overarching goal of this proposal is to begin defining these mechanisms for
the first time using salamander limb regeneration as a model system. Development of therapies that
suppress fibrosis by modulating macrophage function may allow scar-free repair and regeneration of damaged
tissues in humans.
Our proposal will be the first to define how salamander macrophages suppress myofibroblast induction
and scar tissue formation. We will use lineage tracing methods to identify the source of scar producing cells,
which are the cellular targets of anti-fibrotic macrophage signaling. We will then define the macrophage
subtypes that inhibit myofibroblast induction and fibrotic activation signals. Using RNA-sequencing, we will
characterize gene expression patterns in macrophages that suppress myofibroblast induction. These studies
will provide the first mechanistic insights into anti-fibrotic signaling pathways that allow macrophages to support
scar-free healing. Finally, we will test the hypothesis that permanent scar tissue formation may be reversible
by inhibition of lysyl oxidase, an enzyme that mediates crosslinking of the extracellular matrix, which, in turn,
prevents scar-free healing and regeneration.
This proposal is both significant and innovative as it will address a critical gap in our understanding of
how fibrosis and scarring is overcome in a highly regenerative animal model. These new insights will
form an essential step in the development of anti-fibrosis and pro-regenerative therapies for patients. !